A Novel Type VIII Secretion System in Gram-negative Bacteria

PROJECT ABSTRACT/SUMMARY
Bacterial virulence often relies on the ability of pathogens to secrete effectors that facilitate diverse processes
such as biofilm formation and immune evasion. Gram-negative bacteria have evolved to encode secretion
systems to transport proteins across the cell envelope, thereby facilitating pathogenesis. The canonical type VIII
secretion system (T8SS), which is found in Escherichia coli and Salmonella spp., employs the outer membrane
(OM) pore CsgG to secrete curli subunits across the OM where extensive networks of curli amyloid fibers are
formed, serving as a scaffold for biofilm formation. A system closely related to the T8SS is the holdfast anchor
of Caulobacter crescentus, which is a complex consisting of the CsgG homolog, HfaB, and two proteins secreted
via HfaB to the bacterial surface. The complex anchors holdfast polysaccharide to the cell, facilitating biofilm
formation. Therefore, the T8SS and a related system function in biofilm formation through distinct processes.
We recently identified a broadly conserved three-gene operon in Gram-negative bacteria that encodes a
CsgG/HfaB homolog. Notably, this operon is found in numerous pathogens that do not produce curli/holdfast,
implying a divergent role for CsgG homologs. To investigate the function of this operon, we first employed
Acinetobacter baumannii as a model. Intriguingly, we found that mutation of the operon results in the absence
of surface-associated poly-N-acetylglucosamine (PNAG), the major polysaccharide component of Acinetobacter
biofilms. Accordingly, mutants are attenuated in biofilm formation. We next extended our study of the operon to
another Gram-negative pathogen, Pseudomonas aeruginosa. Similarly, mutation resulted in decreased Congo
red binding, indicative of a reduction in biofilm-associated polysaccharides (e.g., Pel and Psl). Accordingly,
biofilm formation was significantly attenuated. Based on this data and the known function of HfaB, we
hypothesize that this three-gene operon encodes a novel variant of the T8SS that is widely distributed
in Gram-negative pathogens and plays a role in attachment of biofilm-associated polysaccharides to the
cell surface. To test this, the following aims are proposed; In Aim 1, molecular approaches will be used to
characterize the localization of and interactions between components of the proposed T8SS variant in A.
baumannii and P. aeruginosa, as well as determine its structure. In Aim 2, we will assess the role of the T8SS
in anchoring polysaccharides to the membrane in A. baumannii and P. aeruginosa. Additionally, we will identify
effectors of the putative T8SS variant in both bacteria. In Aim 3, using A. baumannii as a model, we will
determine the role of the putative T8SS in virulence using the clinically-relevant pneumonia and catheter-
associated UTI (CAUTI) murine infection models. In all, these Aims will assess the function(s) of a novel
secretion system involved in key aspects of pathogenesis in two Gram-negative bacteria of significant public
health concern. Moreover, as this operon is broadly conserved in Gram-negative bacteria, results from this
research will impact our understanding of secretion and virulence of diverse pathogens.

Public health relevance
PROJECT NARRATIVE Bacterial virulence often relies on the secretion of effectors across the cell envelope, which mediate numerous processes including biofilm formation, nutrient acquisition, and immune evasion. Herein, we propose to characterize a putative variation of the type VIII secretion system (T8SS) that is required for surface-association of polysaccharides in the diverse, clinically-relevant Gram-negative pathogens Acinetobacter baumannii and Pseudomonas aeruginosa, thereby facilitating biofilm formation. As this uncharacterized T8SS variant is widespread in Gram-negative bacteria, findings from this research may have broad-reaching implications on our understanding of the biology and virulence of numerous pathogens.